Functional Analysis of Complement Variants in a Genotyped iPSC Epithelial Cell Model System

Complement, a part of innate immunity, eliminates invading microorganisms, apoptotic cells, and cellular debris
to maintain the homeostasis of the cellular environment. The complement pathway is tightly regulated to prevent
the consequences of inflammation. This regulation can be disrupted by disease, infection, aging, genetic
variation or any combination. The long-term objective of this proposal is to uncover the effect of Alternative
Pathway (AP) genetic variations on the local complement response in epithelial cells. Our experiments will be
done on Retinal Pigment Epithelial (RPE) cells differentiated from Induced Pluripotent Stem Cells (iPSCs)
obtained from patients with intermediate Age-related Macular Degeneration. In our first aim we will differentiate
8 iPSCs lines to RPE, four of which have CFH risk alleles and another four which have the risk alleles corrected
to non-risk (isogenic controls). After the iPSCs have reached RPE maturity we will quantitate mRNA and protein
levels and functional capabilities of complement system players (components, regulators and receptors)
synthesized by iPSC-RPE cells. In addition, intracellular AP levels will be determined for iPSC-RPE and their
isogenic controls. These results will inform the influence of genetic variation on secretion of complement proteins
into the extracellular environment, their intracellular content and pathway differences. Because extracellular
vesicles (EVs) are an important cargo for complement and non-complement proteins we will investigate in the
second aim the differences in EV protein content secreted from iPSC-RPE cells from apical and basal membrane
locations. Our working hypothesis is that the EV protein content and quantity will differ between cells which have
the CFH risk variants and their isogenic controls which carry non-risk CFH variants. Secreted proteins also
contribute to deposit formation under the cells, which we will investigate by scanning electron microscopy and
immunostaining. Cells and their isogenic controls will be exposed to smoke extract and cytokines to determine
if the EVs, deposit composition and complement system players (components, regulators and receptors) are
influenced by CFH risk variants. Our preliminary results of single cell RNA sequencing (scRNA-Seq) of RPE
have led to our central hypothesis that complement plays a crucial role in maintenance of healthy RPE. But the
GWAS results on AMD suggest a dysfunction in the complement system. Overall, these studies will provide
unique knowledge about the influence of genetic variation on the complement pathway by its focus on functional
assays. Our interdisciplinary team is uniquely poised to address this fundamental question by combining our
broad background of GWAS and genetic variants of AMD (Stambolian), complement genetics (Atkinson) and
RPE complement and extracellular vesicle analysis (Rohrer). The proposal’s outcomes will fill a critical gap in
our understanding of genetic variants on RPE complement activity and identify new potential therapeutic targets
directed at the RPE. We predict that these results will also have implications for other epithelial cells that serve
as barriers in the kidney and lung, also targets of complement activation in human diseases.

Public health relevance
A balanced regulation of complement is necessary to prevent inflammation. We will assess the consequences of genetic variation to disturb this balance and lead to disease.